Electronic Cigarettes During Pregnancy: Impact on Fetal Development

PROJECT SUMMARY/ABSTRACT In order to investigate Aim 3) fetal neurobehavioral development of the parent grant “Electronic Ciga- rettes During Pregnancy: Impact on Fetal Development” (R01 DA 045492), the proposed administrative supplement to this parent grant would allow the awarded undergraduate research student (Cyrena Mat- ingou) an opportunity to develop psychology related coding skills by utilizing The Fetal Neurobehav- ioral Coding System (FENS). The FENS coding system was developed by MPI Salisbury and incorporates observational data from real-time ultrasound with fetal heart rate and activity data from fetal actocardiography. The FENS was designed to reveal deficits in high-risk and substance-exposed fe-tuses201-204 and has been utilized by our group to study fetuses exposed to maternal depression, substance use, psychotropic medica- tions and conventional cig exposure. In the parent study, we will utilize the FENS to investigate neurobehav- ioral responses to a novel voice stimuli (mother vs stranger) paradigm. Overall, this internship offers students meaningful knowledge and experience in biobehavioral research that may be carried on throughout their un- dergraduate and postgraduate studies and beyond.

Public health relevance
PROJECT NARRATIVE The proposed administrative supplement to this parent grant would allow the awarded undergraduate research student (Cyrena Matingou) an opportunity to develop psychology related coding skills by utilizing The Fetal Neurobehavioral Coding System (FENS) and addresses an urgent and unanswered public health question regarding the impact of e-cigarettes and relative impact of e- cigarettes versus conventional cigarettes on fetal development using novel two and three-dimensional ultrasonography.